Human cardiac microtissues with innate immune sensing to study adverse consequences of genome editing

PROJECT SUMMARY/ABSTRACT
Somatic cell genome editing (SCGE) has remarkable promise to transform our therapeutic toolbox for
the treatment of human genetic disorders. However, despite having the tools available for identification and
modification of human disease-causing mutations, outstanding concerns over efficacy and safety have curtailed
the clinical application of SCGE broadly. Critical gaps in our current knowledge of the safety of SCGE approaches
include: 1) what are the on- and off-target genome editing rates, 2) how do SCGE reagents affect human cellular
and tissue function, and 3) how will the innate and adaptive immune system respond to SCGE reagents. While
clinical trials are effective tools to determine efficacy and safety, they are most efficiently applied after exhaustive
pre-clinical studies have optimized efficacy and safety in other systems. The goal of this proposal is to adapt
biomimetic human cardiac microtissues (CMTs)--engineered from cardiomyocytes derived from human induced
pluripotent stem cells (iPSCs), fibroblasts, and macrophages--to study the impact of SCGE reagents and delivery
systems on a functional human tissue. Because CMTs recapitulate in vivo cardiac three-dimensional
architecture, biomechanical properties, and complex multicellular interactions that are critical to cardiac tissue
homeostasis and function, they are ideal for assaying cardiac functions in vitro. The CMTs have been optimized
for functional assays that quantify a range of dynamic phenotypes that include orders-of-magnitude changes in
tissue contractility, calcium handling, and electrophysiology that predict in vivo cardiac function. Importantly,
CRISPR/Cas9 genome editors have been effectively applied to CMTs to generate monogenic disease models
of common cardiovascular disorders such as dilated and hypertrophic cardiomyopathies that result in heart
failure.
Guided by their comprehensive preliminary data including application of next-generation DNA- and RNA-
sequencing assays to CMTs, the researchers propose to pursue two Specific Aims to determine SCGE efficacy
and safety: 1) interrogate CMTs by comprehensive assessment of contractility, calcium handling and electrical
function in combination with single-cell transcriptomics paired with off-target genome sequencing to identify
adverse consequences of SCGE reagents that target the titin-encoding gene TTN, and 2) engineer autologous
CMTs assembled with two distinct classes of macrophages to study cardiac function and SCGE reagents.
Execution of these Aims will provide multi-scale insights into the safety and efficacy of SCGE reagents
by producing an informative testing platform and system of associated methods to identify adverse outcomes.
Establishing these resources will be a pivotal step toward realizing the promise of genome editing and human
precision medicine of cardiovascular and other disorders.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Human somatic cell genome editing has the potential to transform treatment of cardiovascular disorders in up to 50% of cases. Despite having the tools available for identification and modification of genetic variants associated with disease, outstanding concerns over efficacy and safety of genome editing remain. Here, we apply a 3- dimensional cardiac microtissue model to screen candidate somatic cell genome editing reagents towards delivering on the promise of this transformative therapeutic strategy.